Body Region Specificity for Neuromodulation of the Gut-Brain Axis in Functional Dyspepsia

PROJECT SUMMARY/ABSTRACT
The candidate is an accomplished bioengineer with formal training in human brain-body imaging and
neuromodulation, and a commitment to a career in translational research in the study of integrative medicine
and neurogastroenterology. The candidate’s long-term career goal is to develop a translational research program
in integrative medicine approaches for gut-brain modulation. The candidate’s short-term career goals are to 1)
transition towards independence through mentored training focused on integrative medicine, placebo research,
and neurogastroenterology; 2) weave new research skills into her technical imaging background, with potential
for longitudinal studies evaluating non-pharmacological therapies; 3) produce the data and publications
necessary to transition into a successful R01 application. This application outlines the institutional commitment,
research plan, career development activities, and key mentors involved to ensure the candidate accomplishes
these goals. In recently published work, the candidate has demonstrated the feasibility of using dynamic cine-
MRI for non-invasive characterization of multiple aspects of gastric function in healthy subjects and patients with
functional dyspepsia (FD). In this proposal, the candidate seeks to apply MRI-based tools to compare the impact
of stimulation at different acupoint locations on brainstem neurocircuitry and gastric motility in patients with FD,
as well as the interaction between treatment and expectancy manipulation.
The specific goals of this study are to 1) evaluate the underlying brainstem neurocircuitry of transcutaneous
electrical acupoint stimulation (TEAS) in FD; 2) compare the effect of leg (acupoint ST36) versus abdomen
(acupoint ST25) TEAS on gastric motility in FD; 3) evaluate the effect of expectancy manipulation on meal-
evoked symptoms and physiological outcomes. As an integral part of this proposal, the candidate’s career
development will be complemented by participation in advanced coursework to develop expertise in placebo
research, integrative medicine, gastroenterology, and conduct of clinical trials. A formal mentorship committee,
consisting of multidisciplinary experts in placebo research, neurogastroenterology, neuroimaging, acupuncture,
and integrative medicine, will provide supervision, guidance, and assistance for the candidate to achieve her
goals. The research environment, which includes the Spaulding Rehabilitation Hospital, the Athinoula A.
Martinos Center for Biomedical Imaging, the Center for Integrative Pain Neuroimaging (CiPNI), the
Gastrointestinal Unit and MGH Center for Neurointestinal Health, and the Harvard Medical School will provide a
rich, collaborative, and intellectually stimulating atmosphere to ensure the candidate’s success. Through this
award, the candidate will emerge as an independent investigator by contributing to our understanding of the
brain-gut mechanisms supporting acupoint-specific effects in patients with a disorder of gut-brain interactions.

Public health relevance
PROJECT NARRATIVE Somatosensory autonomic reflexes, which allow stimulation at specific body regions to modulate physiologic response at distant sites, have been linked to acupuncture and acupoint specificity, a particularly relevant concept for the modulation of the gastrointestinal (GI) tract. In this proposal, we will apply advanced, non-invasive imaging approaches to comprehensively investigate acupoint-specific effects on central (brainstem) and peripheral (gastric) function, as well as placebo/nocebo effects generated by expectancy manipulation, in patients with functional dyspepsia (FD). Our study will answer an important translational neuroscience question as to whether rodent acupoint specific responses generalize to humans, and will offer new insights into the role of expectancy for cutaneous stimulation as a therapeutic option for FD.